Role of Annexin A1 expression in HTLV-1-mediated pathogenesis.

PROJECT SUMMARY
The complex retrovirus, human T-cell leukemia virus type 1 (HTLV-1) causes a fatal leukemia known
as adult T-cell leukemia (ATL). In vivo, HTLV-1 primarily infects CD4+ T-cells, with ATL arising when one
infected T-cell undergoes a series of events leading to its immortalization and subsequent transformation, and
ultimately to the disease. This process is believed to be influenced by the genomic site where the provirus is
integrated. Thus, the efficiency of viral infection within the T-cell population is believed to relate to the risk of
developing ATL. Two viral proteins, Tax and HBZ, promote ATL development and maintenance of the
malignant phenotype, and also viral infection. While both proteins regulate transcription, they frequently impart
their effects on the cell by modulating expression of separate sets of genes. In lieu of this pattern, we found
that both Tax and HBZ repress ANXA1 expression, which coincides with repressed ANXA1 expression in
HTLV-1-infected T-cell lines. ANXA1 encodes annexin A1 (AnxA1) a phospholipid-binding protein that, upon
secretion or translocation to the cell surface, acts to counteract inflammation during innate immune responses.
Separately, AnxA1 facilitates early stages of chemotherapy-induced immunogenic cell death (ICD), a process
in which dying cancer cells expose a specific set of damage-associated molecular patterns (DAMPs). These
DAMPs orchestrate signaling that leads to an adaptive immune response to tumor-associated antigens
produced by the cancer cells. Through ICD, cancer cells that have survived chemotherapy are eliminated by
the immune system. We believe repression of AnxA1 expression imparts effects on viral infection and the
chemotherapeutic resistance of ATL. Viral infection requires contact between infected and target T-cells, which
is facilitated by overexpression of specific surface adhesion molecules on infected T-cells that serve as ligands
for integrin complexes on target T-cells. Vascular cell adhesion molecule 1 (VCAM-1) is one adhesion
molecule abnormally expressed by infected T-cells. During innate immune responses, VCAM-1 is upregulated
on endothelial cells to promote stable binding of leukocytes and their subsequent trans-endothelial migration.
AnxA1 binds and blocks access to VCAM-1 to inhibit adhesion between endothelial cells and leukocytes.
Given these observations, Specific Aim 1 characterizes the influence of abnormal VCAM-1 expression in
conjunction with repressed AnxA1 expression by HTLV-1-infected T-cells on viral infection. During early ICD,
AnxA1 is a dual functioning DAMP in that it promotes recruitment of dendritic cells to tumor cell corpses and
also serves as an “eat me” signal for phagocytosis of corpse material. Given these functions, Specific Aim 2
analyzes early ICD-mediated events initiated by anthracycline-induced death of HTLV-1-transformed T-cells,
comparing repressed versus restored AnxA1 expression. Addressing Aim 1 may help establish therapeutic
approaches to reduce the risk of HTLV-1-mediated pathogenesis through inhibition of viral infection.
Addressing Aim 2 may help render chemotherapy for ATL patients efficacious and less toxic.

Public health relevance
PROJECT NARRATIVE Following infection of a T-cell, the virus, HTLV-1, reprograms the cell to repress expression of the cellular protein, annexing A1 (AnxA1). Loss of AnxA1 may help render the cell competent to infect other T-cells, and it may prevent chemotherapeutic agents from eradicating a fatal malignancy caused by HTLV-1 infection. This proposal aims to test if restoring AnxA1 expression in HTLV-1-infected T-cells reduces viral infection and, separately, improves the efficacy of certain chemotherapeutic agents against the malignant, infected cells.